Parrying the Pitfalls of PrEP: Preventing Premature PrEP Discontinuation and STIs among Young Black MSM

Abstract
Young (aged 18-29) Black men who have sex with men (YBMSM) in Atlanta experience high rates of HIV
acquisition (8.9%/year) and STI infection (30%/year). Over the past 5 years, we have followed a cohort of 300
YBMSM in Atlanta and have offered PrEP as part of a comprehensive package of prevention interventions.
We have had substantial uptake of PrEP – over 40% of YBMSM initiated PrEP – but we have also observed
high rates of PrEP discontinuation (39% of all PrEP starts) and ongoing high rates of new STI diagnoses.
Even with 44% PrEP uptake in the cohort, HIV incidence remained high at 6.2%/year. This represents a 30%
reduction in HIV incidence compared to our pre-PrEP comparison cohort, but is still unacceptably high.
Therefore, we proposed to continue our cohort approach but to add three new interventions: (1) an innovative
“early warning” system to identify YBMSM on PrEP who are at risk for discontinuing PrEP, and providing a
motivational interviewing-based peer intervention; (2) offering on-demand PrEP to men who decline daily PrEP
or who plan to stop daily PrEP because they are unwilling to take a daily pill or perceive their risks to be
infrequent; and (3) offering STI PEP with doxycycline for all men, regardless of PrEP use, to avert new STIs.
This is an implementation-focused, single arm cohort approach, using a target trial design to emulate a
randomized trial and evaluation of process measures. Primary outcomes are rates of PrEP discontinuation
and rates of new STI diagnoses.

Public health relevance
Narrative Despite achieving 44% PrEP coverage in our previous cohort of young Black MSM, HIV incidence in the group was still 6.2%/year. To further increase the impact of PrEP, we propose an early intervention to delay or avert PrEP discontinuations, offering of on-demand PrEP, and offering of STI PEP to a new cohort of 300 YBMSM in Atlanta. These interventions will work together to promote PrEP persistence and decrease new STI and HIV infections in these most vulnerable men.